Training in HIV Genomics, Treatment, and Cure Research in Botswana

ABSTRACT
The goal of our parent D43 training grant is to provide training in research focused on HIV treatment, HIV cure,
and HIV genomics research at the Botswana Harvard Health Partnership (BHP), building on advances in
clinical trial and laboratory research infrastructure at BHP that support training opportunities in high-impact HIV
research. This supplement would support two MD trainees in Botswana to conduct two mentored research
projects that focus on different understudied aspects of the health of older women with HIV, a large and
growing group of people living with HIV globally. The first aim (led by mentee Dr. Unoda Chakalisa, primary
mentor Dr. Shahin Lockman) would compare key attributes of menopause in older women with vs. without HIV
in Botswana in a new cross-sectional population of women in Botswana. The second aim (led by Dr. Marcella
Yoseph, primary mentor Dr. Roger Shapiro) would compare pregnancy incidence and adverse pregnancy
outcomes by age group and by HIV status by leveraging the very large (292,000 existing records,
approximately 21% of them from women living with HIV) nationwide Botswana Tsepamo birth outcomes
database. This mentored research will help catalyze the training and career development of these two
promising trainees who are interested in conducting research that will improve the health of women living with
HIV.

Public health relevance
NARRATIVE This project will provide advanced training in the conduct of research in an understudied area: the impact of HIV and antiretroviral treatment on menopause and on birth outcomes in older women with HIV. As women living with HIV age, this is a population that is increasingly important in the global HIV epidemic, but about which little is known. The results of these research projects are expected to contribute to mentee training and to generate preliminary data that will catalyze the career development of two promising trainees, such that they continue research on the health of older women living with HIV.